Determining the role of cellular forces in endoderm differentiation and development

PROJECT SUMMARY/ABSTRACT
The formation of tissues and organs during embryonic development involves the carefully coordinated assembly
of numerous individual cells into a coherent, higher-order structure. Although the molecular and genetic factors
of organogenesis are well-studied, the cell biological processes that these factors regulate, such as cell
migration, motility, and adhesion, are much less understood, and even less is known about role of mechanical
forces in this process. The endoderm is one of the three primary germ layers that ultimately gives rise to the
gastrointestinal and respiratory epithelia as well as other organs such as the thyroid and thymus. During their
development, endodermal cells undergo a radical change in cellular phenotype. During gastrulation, they are
highly migratory but minimally coordinated with each other, a behavior we term “single-cell migration.” Eventually
however, they differentiate into mature epithelial cells within a coherent tissue that performs important barrier
functions within the body. This critical transition period, from dynamic, single-cell migration to epithelial sheet
formation, is especially accessible in the zebrafish embryo owing to its optical transparency and amenability to
long-term microscopy. In preliminary experiments, we found that this transition period is accompanied by
changes in plasma membrane blebbing that are driven by intracellular physical forces, namely membrane-to-
cortex attachment (MCA) and cortical tension forces. In this proposal, we will quantitatively characterize these
physical forces and determine their significance to endoderm development with two specific aims. In the first
aim, we will take complementary in vitro and in vivo approaches to quantitively determine whether and to what
extent MCA and contractile forces are changing during the transition of endodermal cells from single-cell
migration to sheet formation. In the second aim, we will determine the in vivo significance of blebbing-associated
forces specifically to endoderm development by experimentally manipulating blebbing frequency in differentiating
endodermal cells within zebrafish embryos. This work will advance our understanding of the role of cellular
mechanical forces in endodermal morphogenesis, and, importantly, establish a quantitative experimental
pipeline that can be extended to other tissues and future studies.

Public health relevance
PROJECT NARRATIVE Although mechanical forces are increasingly appreciated as important factors in tissue formation, maintenance, and disease, there is still much that is unknown. Progress in this field has been hindered in part by the lack of quantitative tools to measure mechanical forces in living tissues. In this project, we will develop a novel experimental system to measure the mechanical forces associated with development of an embryonic tissue called the endoderm that is the precursor to the gut and respiratory epithelia.